Diet Counseling Intervention for Black Americans with CKD

Project Summary/Abstract:
Excess cardiovascular disease (CVD) mortality among Black Americans with chronic kidney disease (CKD) is
a significant US public health disparity. Compared to their White counterparts, Blacks with CKD develop kidney
disease earlier in life, are 3 times more likely to develop kidney failure necessitating dialysis or kidney
transplantation, and are 1.5 times more likely to die prematurely from CVD. Hypertension, which is also more
prevalent, more severe, and less often controlled in Blacks with CKD compared to Whites, is a leading cause
of CKD and CVD, and a major contributor to the racial disparity in CVD mortality. Therefore, improving
hypertension in Blacks with CKD could have a profound positive impact on an important minority health issue.
The long-term career goal of Dr. Crystal Tyson, who is a nephrologist and hypertension specialist, is to develop
sustainable interventions that improve hypertension and eliminate racial disparities in CVD among adults with
CKD. In her formative work, Dr. Tyson conducted a pilot metabolic feeding study which demonstrated that the
Dietary Approaches to Stop Hypertension diet (DASH) lowers BP in Black adults with CKD without having
adverse effects on metabolic markers of safety. For her career development award, Dr. Tyson is advancing her
research by modifying an existing DASH counseling intervention that was previously demonstrated by her
mentors (Svetkey, Lin) to improve DASH adherence and BP in racially diverse, non-CKD populations, to now
specifically address cultural and disease-specific considerations of Black adults with CKD. For Aim 1, she will
conducted formative qualitative research involving focus group discussions with Black adults with hypertension
and CKD to identify barriers and facilitators of DASH adherence. For Aim 2, she is conducting a randomized
controlled pilot study to test feasibility, acceptability, and the preliminary effect on DASH adherence and BP of
the newly-modified intervention in 50 Black patients with hypertension and CKD. During the award period, Dr.
Tyson has been training to develop (1) new skills in qualitative research methods, (2) new skills to conduct
behavioral and diet interventions in minority and CKD populations, and (3) enhanced skills in health disparities
and minority health research methods. Her highly-accomplished, multi-disciplinary mentorship team is be led
by Laura Svetkey, MD, MHS, an internationally recognized hypertension and clinical trial expert who has
received several institutional awards for her leadership in faculty diversity and mentoring. Dr. Tyson’s team
also includes national leaders in CKD-related health disparities (L. Ebony Boulware, MD, MPH), behavioral
intervention and dissemination research (Gary Bennett, PhD, MPH), qualitative research methods (Laura Fish,
PhD), and biostatistics (Stephen Grambow, PhD). By accomplishing the research aims and training objectives
of this career development award, Dr. Tyson will be prepared to successfully transition to research
independence and develop broadly implementable interventions that help eliminate racial disparities in CVD
among CKD populations.

Public health relevance
Project Narrative High blood pressure (BP) control rates are low among Black Americans with chronic kidney disease (CKD), which causes Blacks with CKD to die prematurely from cardiovascular disease (CVD). The purpose of the study is to develop a behavioral diet counseling intervention that is specifically designed to lower BP in Black adults with CKD. This research has the potential to address an important public health need for therapies that are proven to improve BP control rates and reduce CVD death rates among Blacks with CKD.